Core C: Biostatistics

ABSTRACT – BIOSTATISTICS CORE C
The goal of the Biostatistics Core is to provide support for the statistical analysis generated from three projects.
These supportive functions include the implementation of the study design and data analysis, the development
and applications of innovative statistical methods for single cell genomics and the timely dissemination of findings
as related to publications and research meetings. In summary this support consists of the following:
(1) Provide expert and timely consultative services to Project investigators throughout the course of
research.
(2) Organize clinical data generated from the PPG.
(3) Develop statistical methods suitable for single cell analysis.
(4) Aid in reporting results with the Project teams.
The core team consists of biostatisticians, data management specialists, data scientists, epidemiologists, and
administrative personnel. The Biostatistics Core team will communicate regularly and in a structured format with
project investigators to ensure the appropriate design, analysis and interpretation of preclinical and clinical
experiments of the PPG. The Biostatistics Core has experience and expertise across the breadth of biostatistics
including within the domains of computational genetic data set analysis, analysis of biological pathways, clinical
trial design and analysis, and observational study design and analysis. This support will include the planning of
new studies with regards to experimental design, estimation of sample size and power calculations, and methods
for randomization when appropriate. The Biostatistics Core will collaborate with the PPG investigators in all
stages of research, from the formulation of the research questions through study design, data management, and
data analyses for laboratory studies (Projects 1-2), studies involving human tissues, observational and clinical
trial studies (Project 3), and principal interpretation for dissemination. The Biostatistics Core will closely
coordinate with the Administrative Core A and the Cellular, Genomics and Imaging Core B to ensure timely
completion of research objectives, efficient use of shared resources, effective dissemination of research findings,
and compliance with regulatory policy and reporting requirements.

Public health relevance
NARRATIVE – BIOSTATISTICS CORE C The large scale of genomic and clinical data that will be generated by the Program Project Grant (PPG) offers innumerable opportunities. The Biostatistics Core is advantageously positioned to develop study designs and novel computational methods which will ensure completion of the research projects within the PPG and serve as lasting scientific resources for the broader biomedical community.